Lead (Pb) toxicity on mechanisms of neurodevelopment by dysregulation of thyroid hormone distributor proteins in Xenopus laevis

This document has not changed.

Public health relevance
This document has not changed.